Liver Kinase B1, a genetic risk factor for multiple sclerosis

During the course of recruiting MS patients for a study of PBMCs, a family with 5 siblings diagnosed
with MS was identified. The presence of a co-morbidity for certain rare tumors led to sequencing
analysis of tumor suppressor gene STK11, and a variant (small nucleotide polymorphism, SNP) was
identified. Genotyping of a large number of DNA samples showed that this SNP is present at higher
levels in MS patients in both Caucasian and African American cohorts. STK11 codes for the Liver
kinase B1 (LKB1) which has roles in regulation of cellular metabolism and inflammatory responses in
Tcells, glial cells, and oligodendrocytes. Since the role of LKB1 in MS has not been characterized,
and since brain astrocytes play an important role in maintaining energy balance and restricting
immune responses, we hypothesized that reducing astrocyte LKB1 expression or activity would
worsen EAE. Our findings using mice with LKB1 knocked out from astrocytes (“cKO mice”) confirmed
this hypothesis and identified pathways that are altered in the astrocyte deficient mice and cells.
In this project, we will determine how LKB1 deficiency in astrocyte effects their metabolic properties
(mitochondrial function, and production of lactate which can be provided to neurons on demand). We
will test the effects of the media prepared from the astrocytes (“Conditioned media”, CM) on microglial
cells to see if microglial cell activation is increased. We will add astrocyte CM to naïve Tcells to see if
the CM converts them into a damaging phenotype (Th1 or Th17; cells that produce toxic substances
during EAE and MS). We will test effects of the CM on neurons, to see if the astrocytes produce
neurotoxic substances; and add CM to oligodendrocytes to see if maturation is reduced.
In our studies, we found that one of the proteins most increased in astrocyte cKO mice was lipocalin 2
(LCN2), a protein involved in inflammatory responses in other diseases, and highly expressed in
astrocytes. However, roles for astrocyte LCN2 in EAE are not well known. We will generate new mice
where astrocyte LCN2 is knocked down, to see if that reduces EAE disease. We also found that in
astrocyte LKB1 cKO mice, there was extensive damage occurring to motor neurons in the spinal
cord, which could contribute to weakness in MS patients. The cause of that damage is unknown,
however findings that there is a large accumulation of immunoglobulins in those neurons suggests
that these cells have increased expression of an IgG receptor. Experiments to test this are proposed.
Finally, while our studies are using conditional knockout of LKB1 from cells, we do not know if the
STK11 SNP, which does not cause knockout but alters LKB1 levels, has the same effect. To address
this, we will use a novel method to generate microglial cells from human peripheral blood monocytes.
Although microglia differ from astrocytes, we will be able to compare the responses of microglia with
the normal, wildtype STK11 gene to those having the STK11 SNP.
Overall, these studies will expand our knowledge of how LKB1 regulates the development of MS and
EAE, and identify new targets for therapeutic interventions in MS patients who have deficiencies in
LKB1 expression.

Public health relevance
This project continues our studies to understand how the protein Liver Kinase B1 contributes to the progression of disease in MS; and developing ways to treat patients who harbor deleterious variants in this gene.